PREVALENCE OF PRIMARY ADRENAL INSUFFICIENCY IN ALD HETEROZYGOTES

This study is to determine the prevalence of overt and subclinical primary adrenal insufficiency in ALD heterozygotes and to determine which dynamic endocrine tests are best suited for its detection.